Research and development of an adverse outcome pathway-focused mechanistic inference tool for 'omics data using semantic knowledge graphs

Project Summary
1 Adverse outcome pathways (AOPs) are risk assessment tools that provide a transparent, mechanistic description of a
2 stressor resulting in an adverse outcome. Each AOP describes a logical sequence of measurable, causally linked events at
3 varying levels of a biological hierarchy (e.g., molecular, cell, organ, and population). Starting with exposure to a stressor,
4 and proceeding through a series of key events, each AOP terminates with an adverse outcome for the health of an
5 organism or population as a whole. Despite the great popularity of AOPs in risk assessment, there are few tools that can
6 exploit the rich mechanistic information they provide, especially quantitatively and in an automated setting. The lack of a
7 systematic framework for representing AOPs in a way that is amenable to quantitative analysis is an important obstacle
8 that limits their regulatory applications. We have developed a unique system, TOXGRAPH, to address the aforementioned
9 limitations. TOXGRAPH integrates biological and biochemical knowledge across a heterogeneous collection of open
10 biomedical ontologies and public databases: a massive, tissue-specific semantic knowledge graph (KG) curated entirely in-
11 house. We have also developed a deep learning-based model that maps unstructured textual AOP descriptions to specific
12 concepts in this KG. To take advantage of these semantic AOP representations, we have developed a framework that
13 allows us to turn AOPs into hypothesis validation tools, by generating enrichment statistics of AOPs an their individual
14 events. This approach can significantly simplify downstream analysis by calculating enrichment statistics at varying levels
15 of granularity, using the results of experimental datasets, such as the results of differential gene expression experiments
16 to quantify AOP enrichment.
17 The research we propose encompasses three specific aims: (1) improve our AOP enrichment statistics; (2) enhance our
18 NLP mapping of AOP event descriptions to biomedical knowledge graph concepts; (3) software engineering for improved
19 user experience with interactive visualizations. In the first aim, we will improve our model to account for multiple
20 experimental doses and time points concurrently for the enrichment of AOP events. In our second aim, we will improve
21 our semantic similarity model to map arbitrary AOP event descriptions to a controlled vocabulary. For this research, we
22 will employ state-of-the-art machine learning, NLP and text mining methodologies. In our third aim, we will develop a
23 web interface to the current command line tool which besides producing the same enrichment results and mechanistic
24 hypotheses will allow users to navigate the results in a lightweight, interactive 3D space. We envision this as a powerful
25 exploratory tool to generate mechanistic hypotheses, with the added ability to show enriched relations across time
26 points in this 3D space.
27 Our overarching goal is to provide an easy, intuitive, and unbiased (data-driven) framework for querying AOPs and
28 researching mechanism of action. TOXGRAPH will directly contribute towards the development of novel non-animal
29 testing strategies and streamline regulatory decision making. Fundamentally, it will greatly facilitate the intended use of
30 AOPs for regulatory applications: to help minimize the uncertainty in decision making.

Public health relevance
Project Narrative AOPs have been embraced by regulatory agencies as a tool to establish a systematic, mechanistic understanding of exposure response, with applications ranging from drug development to safety assessment and regulation of chemicals. Our tool based on semantic knowledge graphs will provide an easy, intuitive, and unbiased (data-driven) framework for querying AOPs and researching mechanism of action. These efforts will serve to validate AOPs in a quantitative, reproducible manner, and directly contribute towards the development of novel non-animal testing strategies and streamline regulatory decision making.